Innovative oral regenerative therapy leveraging immunoregenerative mechanisms.

This supplement will support Oridivus, LLC to participate as part of the I-Corps program, focused on developing our business model canvas to assess the gaps in our approach to the oral wound healing market. During the I-Corps program we will perform over 100 interviews identifying the key stakeholders in the oral wound healing environment including dentists, oral surgeons, periodontists, and otolaryngologists along with the specific user needs of each different speciality. At the conclusion of the I-Corps program we will have identified the beach head market, a plan to address an unmet need in the market and continued to refine our business model canvas based on our ongoing customer and ecosystem discovery.

Public health relevance
Project Narrative: Following injury to the lining of the mouth, or the oral mucosa, caused by cleft palate repair (1:1000 live births), wisdom teeth removal (10 million/year) or trauma (1 million/year), there is a high incidence of wound healing complications up to 60%. Oral wound healing complications occur due to a lack of a regenerative oral wound healing therapy, leading to feeding, speech, pain and ultimately require revision surgery. This proposal is focused on developing a regenerative approach to oral wound healing leveraging the activity of FTY720.